Three-Photon Microscope for Fluorescence and Phosphorescence Lifetime Imaging

Project Summary/Abstract
This application requests funds for purchase of a three-photon microscopy system with fluorescence and
phosphorescence intensity and lifetime imaging capabilities that will constitute a shared facility in the
Neurophotonics Center at the Boston University (BU). Three-photon microscopy is becoming an important tool
for biomedical research, providing the ability to image intact brain tissue to depths of up to >1.2 mm, with sub-
micron resolution. We have assembled an outstanding broadly based group of NIMH- and other NIH-funded
Users from multiple departments at BU with a major focus on using model organisms to understand how neuronal
circuits control behavior. On the pre-clinical side, our Users study how these circuits go awry in neuropsychiatric
and neurological disease. We expect the User base to grow, as new projects get funded, and as we attract
additional investigators. The proposed research projects require deep penetration of light in tissue, a requirement
that will be addressed by the proposed state-of-the-art three-photon microscopy multi-user facility. The requested
system was chosen because it allows versatile imaging of deep brain’s structure and function under in vivo
conditions, supports three-photon Fluorescent Lifetime Imaging Microscopy (3p-FLIM) and three-photon
Phosphorescence Lifetime Imaging Microscopy (3PLM), has high image quality and is compatible with the
existing software and hardware platforms at the Center.
Administratively, the proposed instrument will be part of the Neurophotonics Center. The Center provides
comprehensive imaging facilities for users at BU and the greater Boston area, with established infrastructure for
resource administration, recharge mechanisms, and User training. The proposed three-photon instrument is
complementary to the existing neuroimaging modalities at the Center such as two-photon and confocal
microscopes and will provide an essential and central component of BU’s investment in neuroscience,
neuroimaging and neuroengineering. Further, the proposed facility will serve as a collaboration vehicle
strengthening multidisciplinary ties across BU’s departments and between the Charles River campus and School
of Medicine.
In summary, the proposed cutting-edge three-photon microscopy facility will provide NIH-funded
investigators at BU with an essential tool to study the intricate pathways involved in deep brain function, features
of neuropsychiatric and neurological disease progression, disease diagnosis and treatment. These studies will
impact our understanding of normal and pathological brain function, opening new avenues for treatment and
prevention of human disease. The proposed facility is also expected to play a significant role in the training and
teaching efforts at BU.

Public health relevance
Project Narrative This application requests funds for purchase of a shared three-photon microscope that will provide NIH- funded investigators at BU and the greater Boston area with an essential tool for basic science studies of brain circuits that control behavior in animals models as well as pre-clinical investigations of how these circuits go awry in neuropsychiatric and neurological disease. We have assembled an outstanding broadly based group of Users from multiple departments at BU whose research projects are aligned with the mission of NIMH and NIH.